Novel signaling molecules regulating platelet activation

Platelets play a crucial role in hemostasis and thrombosis, and more and more studies indicate their
role in other disease states including inflammation, cancer, and atherosclerosis Platelets express a
number of surface receptors, which through their activation, allow platelets to interpret their local
environment and to detect vascular lesions and promote hemostasis. My group focuses on these
signaling steps and how their interplay mediates platelet activation. Understanding signaling networks
and their regulation has been my research focus for the past two decades and our group has made
important contributions to the platelet-signaling field. My research goals are to identify novel signaling
molecules that regulate main signaling pathways, characterize novel signaling pathways emanating
from the same signaling molecule, and understand the differences in various tyrosine kinase
pathways in platelets. My additional goals are to understand what changes occur in platelet
composition, including miRNAs, with age and disease, such as diabetes, that make them more
susceptible to thrombotic events. This work builds on our past contributions in the field and a host of
reagents and genetic tools that we have amassed. In this proposal, we place particular emphasis on
the intracellular interactions that regulate a signaling molecule. One of the novelties of the studies
proposed is that the same protein kinase, through differential tyrosine phosphorylation, activates
diverse signaling pathways, which have distinct roles in hemostasis. The studies proposed in this
application will provide further insights into the regulation and identification of novel signaling
pathways in platelets, which may be applicable to other cell systems expressing similar receptors and
could form the basis for novel therapeutic targets to treat thrombosis and thrombocytopenia. In
addition, understanding these signaling cascades in platelets will help us evaluate and predict
possible implications of the therapeutic agents that could interfere with these pathways. For example,
our studies anticipate that Ibrutinib, a Tec kinase inhibitor used for the treatment of chronic
lymphocytic leukemia, will block the CLEC2 pathway in platelets and cause blood flow into lymphatic
vessels. I would like to pursue these goals in the next decade with the same vigor and intensity that
have employed in the past two decades. have been funded by NIH for about 22 years on the platelet
signaling paradigms and have published over 180 papers (on an average of 8 papers a year). The
OIA will alleviate the need to submit separate thematic grant applications to various agencies with
coherent specific aims and will allow us to make significant contributions to the understanding of
platelet signaling networks. Our overarching goal is to understand how the network of receptor-
mediated signaling can be manipulated to control platelet function.

Public health relevance
Project Narrative: An in depth understanding of the novel signaling molecules and pathways in platelets will help us understand how signaling pathways are regulated in other cells. Understanding these signaling cascades in platelets will help us evaluate and predict possible implications of the therapeutic agents that could interfere with these pathways.